SAFETY AND EFFICACY OF ZDV FOR ASYMPTOMATIC HIV INFECTED INDIVIDUALS

To evaluate the safety and efficacy of ZDV at two dosages compared to place in long term administration to HIV infected individuals